The influence of mesolimbic-hippocampal interactions on episodic memory during active information seeking

PROJECT SUMMARY
Interactions between the hippocampus and mesolimbic dopamine system supports memory encoding and
subsequent consolidation to stabilize salient information in long-term memory. These episodic traces are used
to support a variety of adaptive behaviors, including inference, generalization, and decision-making.
Information seeking further represents a context in which motivated learning occurs in the absence of explicit
reward, including incubation-induced craving and context-dependent feedback. In this way, information seeking
may serve as a model to dissect how mesolimbic-hippocampal circuits contribute to the complexity of drug
seeking behavior. Most research characterizing the contributions of mesolimbic-hippocampal interactions on
memory have focused on reward. However, this circuit is also critically involved in memory enhancements
resulting from active exploration. Critically, memory enhancements during active information seeking involves
the integration of mesolimbic signaling across multiple elements of an event (cues versus outcomes) and
timescales (event-evoked versus state-dependent). Rodent studies show that hippocampal engagement during
exploration triggers a positive feedback loop, which increases tonic dopamine signaling in the ventral
tegmental area (VTA), which in turn yields larger VTA anticipation and feedback responses. Prominently, these
positive feedback loops could instantiate and propagate the variety of behaviors contributing to substance use.
We propose to characterize how state-dependent VTA responses relate to memory enhancements during
active information seeking using a combination of novel behavioral paradigms, state-of-the-art neuroimaging,
and computational modeling to inform mechanisms underlying memory. Aim 1 will study mesolimbic-
hippocampal contributes to memory encoding during active learning and hypothesis testing. Aim 2 will study
how engagement of this circuit during encoding stabilizes memory representations during periods of post-
encoding consolidation. Finally, Aim 3 will utilize a computational psychiatry approach to study how individual
differences in memory during active information seeking relates to predictors of substance use risk.

Public health relevance
PROJECT NARRATIVE Interactions between mesolimbic dopamine systems and hippocampus are tailored to support the active acquisition of salient information into long-term memory, a process that supports a variety of adaptive behaviors such as memory selectivity, generalization, and decision-making. Similarly, this circuit contributes to motivated behaviors that occur in the absence of explicit rewards which are relevant to substance abuse — such as craving and relapse. This proposal examines how mesolimbic-hippocampal interactions contribute to episodic memory in the context of active information seeking to build a framework to understand how mesolimbic signaling at multiple timescales interact to shape memory encoding and consolidation in the absence of explicit reward feedback